Characterization and Clinical Course of Symptoms and Gastric Emptying in Pediatric Participants with Symptoms of Gastroparesis

Summary/ Abstract of Parent Award
Title: The NIDDK (National Institute of Diabetes and Digestive and Kidney Diseases)
Gastroparesis Registry 3: Characterization and Clinical Course of Symptoms and Gastric
Emptying in Patients with Symptoms of Gastroparesis
Background: The NIH GpCRC has generated an extensive number of gastroparesis (GP)
related studies, which have increased our knowledge and concepts of understanding of this
condition, its complications, diagnostic challenges and clinical outcomes. The most current
study was called The Gastroparesis Registry 3 (GpR 3), which now is recognized as a Parent
Project/Award (Federal Identifier: DK74035).
Objectives of GpR3 are: 1) To expand a registry of patients for the study of the epidemiology,
etiology, and degree of morbidity associated with gastroparesis. 2) To continue to follow and
expand the data collections 3) To provide a reliable source for recruitment of well-characterized
patients with GP for therapeutic clinical trials, pathophysiological, molecular, histopathologic, or
other ancillary studies.
Methods: We enrolled diabetic, idiopathic and post-Nissen fundoplication gastroparesis
patients with delayed and normal gastric emptying. TTUHSC EP was able to enrolled 104 out of
400 participating subjects. Baseline data collection included demographic, socioeconomic
characteristics and all measures capturing information requested by the protocol. In 2020
COVID-19 study was implemented to assess whether COVID-19 is associated with
development of post-infection GP.
Results: The parent project, Gastroparesis Registry 3 (GpR3), is still an active study that
collects data from qualified and already enrolled patients with symptoms of and like-
gastroparesis. Epidemiological, clinical, physiological, and patient outcome data is being
collected to characterize the patients and their clinical course to better understand this disorder.
The long-term goal is to help phenotype patients into pathophysiologically defined subsets. This
classification will provide a foundation for translational research, facilitating the search for
etiopathogenesis and enhance the ability to define and conduct large clinical trials, ultimately
leading to the development of more rational and effective therapeutic approaches for
gastroparesis. GpR3 recruited patients who are 18 years of age and older. The new sub-project,
The Pediatric Gastroparesis Registry2 (PGpR2), aims to assess the same objectives in patients
between the ages of 8 and 24 years old, who are seen in the pediatric GI multicenter clinics.
Specifics on this pediatric study are presented in an attached grant application, which
designated PI/PDs Dr. McCallum and Dr Sarosiek as supervisors and mentors responsible for
the advisory role and outcomes of Dr Francis, Pediatric GI PI, and conduct of the study.

Public health relevance
Project Narrative Gastroparesis is a disorder of gastric function characterized by delay in gastric emptying and frequently associated with chronic nausea and vomiting, early satiety, and abdominal pain, and can have a devastating impact on quality of life. The Pediatric Gastroparesis Registry 2 aims to expand on the first registry of pediatric patients with symptoms of gastroparesis for the enhanced study of symptoms, gastric motility abnormalities, patient characteristics, and degree of morbidity. This cohort will be followed to further define the natural history and clinical course of pediatric patients with symptoms of gastroparesis, and will provide a source for recruitment for other studies, including therapeutic clinical trials, pathophysiological, molecular, histopathologic, or other ancillary studies.